Advanced Technology Core (Core H)

CORE H

Modified Project Summary/Abstract Section

The technological advancements of the last two decades in the area of biomedical research for HIV have been nothing short of breathtaking and are propelling the next generation of new insights into cellular and systemwide functionalities at an ever-increasing speed. Access to these technologies is key for cutting-edge research programs, however, no single laboratory can cover the breadth of the high-end research tools that are now available and provide complete expertise. The mission of the University of Alabama (UAB) Center for AIDS Research (CFAR) Advanced Technology Core (ATC) is to maximize the benefits of novel key technologies for HIV researchers by providing the necessary instrumentation and services within a centralized facility that is capable of handling potentially infectious material.
We have used the last two CFAR funding periods to expand the high-tech service portfolio of the core from a flow cytometry centered operation to one that also offers access to transcriptomic and phospho-proteomic services. The ATC now offers access to and institution-wide services for a total of 6 high-end cell sorters and 5 analytical flow cytometers as well as an ImageStream. The ATC further offers scRNA-seq analysis and spatial transcriptomic services. To facilitate comprehensive services for users, the ATC also provides sample preparation services, phospho-proteomic analysis, and task-specific bioinformatics pipelines. The continuing critical impact of the core is demonstrated by its productivity. In the current funding cycle, the ATC services supported HIV researchers to publish >54 papers and be awarded 22 HIV-related grants, a strong achievement for a Tier 1 CFAR Core. As a result of the ATC being consolidated with the UAB Comprehensive Flow Cytometry and Single Cell Analysis Core, the consolidated core provided services to a total of 266 NIH grants and 341 Principal Investigators. The synergies arising from this large institutional userbase demonstrate the ability of the ATC to provide a research and service infrastructure exceeding that of a core that exclusively serves HIV researchers. In the next funding cycle, the aims of the ATC are:
1. To provide access to state-of-the-art flow cytometric analysis capabilities and services
2. To provide access to high-data content generating transcriptomic and proteomic methods
3. To conduct training, mentoring, and outreach
4. To provide an internal and external data sharing infrastructure
Through these aims, the ATC will continue to fulfill its mission to provide access to high-end technologies and quality services in support of innovative research and to be a research incubator facilitating collaborations between non-HIV and HIV researchers and contributing to the development of a pipeline of new HIV researchers.